Project ACE -- ACtion for Equity: A BUILDing SCHOLARS Pipeline

PROJECT SUMMARY
Project ACE (ACtion for Equity: A BUILDing SCHOLARS Pipeline) proposes to create a pipeline of
academically and socially prepared Hispanic students from three economically disadvantaged high schools in
Far West Texas and Southern New Mexico who will pursue undergraduate majors and eventually careers in
biomedical science research. Drawing on The University of Texas at El Paso's (UTEP) BUILDing SCHOLARS
(Building Infrastructure Leading to Diversity: Southwest Consortium of Health-Oriented education Leaders and
Research Scholars) grant and couched in Johnson and Bozeman's (2012) asset bundles framework, Project
ACE is unique because it exposes students to interdisciplinary biomedical research at the high school level;
incorporates their teachers in research experiences; and engages students' families in their academic and
research skills growth. The proposal seeks to accomplish its goal of increasing diversity in the biomedical
sciences through creating a pipeline of prepared Hispanic high school students by: (1) enhancing their high
school teachers' research skills and knowledge of careers in biomedical research through participation in
mentored summer research experiences; (2) fostering a culture of high academic achievement amongst high
school students through rigorous classroom instruction using research-infused curriculum that will be
complemented by tutoring, SAT/ACT preparation and résumé writing; and (3) developing a research culture for
high school students, where high school students will be engaged in research activities. High school students
will be socialized into science through yearly symposia, and interaction with near-peer mentors, graduate
student tutors and UTEP faculty members who will serve as research mentors. This entails a multi-tiered
mentoring approach which involves research to be performed at both the student's high school as well as at
UTEP. By engaging in research at the high school level, we expect to see increased science identity and
research self-efficacy in the participating students; improved research skills and increased interest in
biomedical careers. By fostering a culture of high academic achievement, we expect that participating students
will become more competitive applicants for merit-based scholarship opportunities at the postsecondary level
and be more prepared for the biomedical research workforce. By involving high school teachers in
contemporary biomedical research and infusing research and active learning principles into high school
curriculum, we expect their students to be more engaged in learning, more excited by biomedical research,
and more likely to pursue biomedical majors as undergraduates. This proposal is significant because it will
leverage BUILDing SCHOLARS and NIH-funded programs at UTEP in order to further contribute to the
diversification of the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE The percentage of underrepresented minorities in the biomedical careers is below the corresponding percentage for majority groups. The primary emphasis of Project ACE -- ACtion for Equity: A BUILDing SCHOLARS Pipeline is to increase the number of underrepresented students from historically and economically disadvantaged backgrounds in the biomedical fields through instruction based on a research- infused curriculum. By exposing students to biomedical research at the high school level; incorporating their teachers in research experiences; and engaging students' families in their academic and research skills growth, Project ACE will create a pipeline of Hispanic students from economically disadvantaged high schools who are prepared academically and socially to pursue biomedical careers.